Longitudinal trajectories of early childhood respiratory symptomatology and their impact on behavioral development

Project Summary
This application for a K23 mentored career development award integrates structured career mentorship and in-
depth research training with a detailed research plan is designed to foster the career as an independent
investigator of Jonathan S Litt, MD, MPH, ScD is a neonatologist at Beth Israel Deaconess Medical Center and
Instructor of Pediatrics at Harvard Medical School. At the completion of the award period, Dr. Litt achieved a
high level of methodological expertise in advanced data collection and analytic techniques and their application
to the intersecting trajectories of chronic respiratory ailments and developmental comorbidities and developing
interventions aimed at improving functional outcomes in high-risk populations. Dr. Litt's career development
plan involves training in 1) using large data sets to develop and test hypotheses, 2) managing patient-oriented
research with large cohorts, and 3) using advanced methods for longitudinal trajectory analysis. The
overarching scientific aim of this K23 award proposal is to elucidate the relationship between the development
of chronic respiratory disease (wheezing, asthma) and behavioral problems in a clinical sample of high-risk
preterm (PT) infants with chronic lung disease (CLD) and a large population-based birth cohort. Understanding
this relationship will help inform the content and timing of targeted interventions to decrease functional
morbidities and prevent disabilities, particularly in high-risk populations. Aim 1 is to assess the longitudinal
relationship between wheezing-related respiratory status and behavior problems in healthy term-born children.
Aim 2 is to describe the emergence and trajectory of respiratory symptoms in among PT infants with CLD. The
findings of the proposed studies will fill key gaps in understanding of how physical health and behavioral
functioning interact over time and inform the timing, suggest content of interventions for reducing morbidities
associated with chronic disease in childhood and provide the basis for an R01 grant. Following the K23 award
period, Dr. Litt will be well-positioned to apply for further federal funding as an independent investigator to
develop test evidence-based interventions.

Public health relevance
Project Narrative Respiratory problems such as chronic lung disease (CLD) and atypical behavior development are common morbidities associated with preterm (PT) birth, but information on symptom trajectories is limited. More is known about asthma, the most common chronic condition of childhood. Drawing on models of asthma symptomatology, this research proposal aims to describe symptom trajectories of children with CLD and understand how the emergence of respiratory disease during childhood intersects with the development of behavior problems.